Supporting RADx Technology Development: Leveraging International Networks and Clinical Context

PROJECT SUMMARY
The COVID-19 pandemic is undergoing a new wave of infections in the US fueled by new, highly transmissible
variants of concern and waning vaccine immunity. The need for more, rapid diagnostic tests is clear. In this
proposal, we will build on the success of the Johns Hopkins POC Technologies Research Center for Sexually
Transmitted Diseases which has been leveraged to support the Rapid Acceleration of Diagnostics Technology
Program. In this supplemental grant proposal, we have 4 aims: 1) to add an international COVID-19 clinical
research site for diagnostic testing and biorepository development at the Infectious Diseases Institute in
Kampala with the team with whom we have been collaborating for 2 cycles of POCTRN funding and where
vaccination rates are low and there are on-going waves of infection; 2) to continue to convene the highly
successful Clinical Review Committee for RADx Tech Wave 2 and add on desktop evaluations of in vitro
devices; 3) to use next generation sequencing and microarrays to monitor variants and other respiratory
pathogens that cause influenza-like illness; and 4) to provide support for specific companies needing
technology development expertise and biospecimens to accelerate development.

Public health relevance
PROJECT NARRATIVE As part of the RADx Tech program, the Johns Hopkins Point-of-Care Center proposes to support companies to develop SARS-CoV-2 direct detection diagnostic devices through clinical review committee review, enlarging the pool of specimens available for device evaluation, and initiating a site for prospective evaluation of devices suitable for resource-limited settings like Uganda.